Administration and Enrichment

ABSTRACT – Core A
The goal of Core A (Administration and Enrichment and) will be to ensure that the Resource Center for
Translational Muscle Research (CTMR) successfully accomplishes its objectives of enhancing skeletal muscle
research efficiency, develop new tools and therapeutic approaches and recruits new investigators into skeletal
muscle research at the University of Washington. The approach of Core A will be to provide administrative
support, evaluation of core functionality, and coordinate enrichment activities. These responsibilities are
divided into six aims to provide 1) leadership, 2) management and evaluation, 3) recruit new members and
promote collaboration, 4) provide pilot grants to promote project development and have a funding mechanism
for high risk - high reward research, 5) facilitate communication and translation, and 6) provide enrichment
activities, training opportunities and other mechanisms to promote translational muscle research at the
University of Washington.